Heparin-free extracorporeal circulation via combined nitric oxide releasing/generating surfaces

Project Summary/Abstract
The major limiting factors to clinical applications of blood-contacting materials, ranging from small catheters to
large extracorporeal circulation (ECC) devices, include platelet activation leading to thrombosis and infection.
Thrombus formation can further lead to obstruction of blood vessels, device malfunction, or even life-threatening
situations such as embolism. Systemic anticoagulation is required to prevent clotting in the devices; however,
one of the resulting major complications of this is bleeding. During the COVID-19 pandemic, extracorporeal
membrane oxygenation (ECMO) has received critical attention as a therapy for patients where mechanical
ventilation alone is ineffective. Significant challenges remain due to the increased risks of thrombosis in the
circuitry that can be further exacerbated by hypercoagulable blood exhibited by COVID-19 patients. Therefore,
there is an urgent necessity and opportunity to combine strategies for preventing thrombosis and infection into
multifunctional device coatings for enhanced patency and safety.
Our work and others have demonstrated that nitric oxide (NO) release from polymers prevent platelets activation
and infection. This technology mimics the vascular endothelial cells lining the blood vessels, as well as other
cells in our bodies, producing NO locally to prevent clotting and bacterial biofilm and subsequent infections.
Recently we discovered that all of the positive effects can be achieved from polymers physically blended with
the NO donor molecule S-nitroso-N-acetylpenicillamine (SNAP), which is nontoxic, inexpensive, and easy to
synthesize. Active NO release from the NO donor functionalities in the polymer reduces thrombosis and bacterial
infection polymer-blood interface; however, the NO-release strategy alone is limited by the finite reservoir of NO
donor functionalities within the polymer that limit the duration of the NO availability at the polymer-blood interface.
Our recent work has shown the potential of combining active NO-release with catalytic NO-generating
mechanism in a single polymer. The goal of this proposal is to develop a polymer comprised of a NO donor
covalently bonded to the polymer to provide active NO-release (without leaching) in combination with
immobilized selenocystamine moieties to provide long-term NO-generation. This polymer will combine
NO-release and NO-generating strategies for the first time, resulting in a new generation of polymers
that possess potent broad-spectrum antimicrobial properties and reduce thrombosis by inhibiting
platelet adhesion/activation. The new polymers will be applicable to any blood-contacting device; however,
this proposal will focus on studying the combined NO-releasing/NO-generating strategy in vitro for antimicrobial
properties and in a rabbit extracorporeal circulation model for prevention of thrombosis. Successful completion
of this project will allow progression to early clinical trials and development of a new generation of extracorporeal
circuits that can reduce complications while improving the success of patient care.

Public health relevance
PROJECT NARRATIVE The ideal antibacterial and hemocompatible surface would prevent platelet adhesion and activation, thrombosis, and microbial biofilm formation. This research project will develop and evaluate the synergistic effects of S- nitrosothiol based nitric oxide (NO) release along with a surface immobilized catalyst that can extend the therapeutic levels of NO for longer periods at the polymer interface to prevent platelet activation/adhesion and provide antimicrobial activity, thereby solving major clinical problems associated with extracorporeal circuit (ECC) applications and enabling successful ECC without heparinization.